Use of gold-based photothermal nanomaterials for the comminution of kidney stones

Project Summary (30 lines max):
The goals of this proposal are to develop a novel nanotechnology based treatment for kidney stones and also
to support the career development of Ian Houlihan, PhD. in his research on developing nanotechnology based
treatments for urological diseases. Research: Kidney stones are a common disease with reported poor stone
free rates (as low as 40%) with current clinical methods of treatment which results in a high reoccurrence rate
(~40%) of the disease. Current clinical treatments for this disease are not without drawbacks, with the major
drawbacks being the use of radiation to visualize the stone, direct contact between laser fiber and the stone is
required, and damage to surrounding tissue due to the high absorption of laser energy in the water region.
With the new technology that is proposed here a number of these drawbacks can be addressed resulting in a
safer and more effective treatment for the patient and clinician. This project will first investigate how this new
technology causes stone comminution, this will be done by carrying out a baseline characterization of the
nanomaterials and human kidney stones being used. This will inform what the minimum energy is required to
cause stone breakdown and define the parameters needed for the in vivo application of this technology. It will
also investigate the two predominant modes of failure with using these nanomaterials, this mechanism is
believed to be a dual mode mechanism of photothermal and photoacoustic energy generated by the gold
nanomaterials when irradiated with a near-infrared laser source. Secondly this project will develop stone
targeting nanomaterials that will specifically bind to the kidney stone. These newly developed nanomaterials
will be characterized and their ability to convert laser energy to heat and acoustic forms will be quantified.
These targeting nanomaterials will be tested for safety in a number of different ways, firstly they will be tested
for any toxic effects on urothelial cells, secondly they will be tested with an ex vivo porcine model to ensure
they cause no adverse reactions to the kidney tissue, lastly these nanomaterials will be tested in a murine
model to show their safety in an in vivo model. The last aim of this proposal is to conduct a pilot study on the
efficacy of this technology in a porcine model. This new technology will be compared to the clinical gold
standard, laser lithotripsy. The model will also be used to assess how effectively and safely our technology
performs in a live animal. Career Development: The investigator has a technical background in engineering
and experience in developing materials for medical applications and aims to use this award to help in learning
new skills in developing and executing cellular and animal based studies for the development of new
treatments for urological disease. The career development plan has a number of different courses specifically
in learning about histopathology, biology of the kidney and statistical analysis for medical sciences. Training
includes workshops at the NIH funded kidney research center in Pittsburg University focused on pathology and
imaging of kidney disease states. A diverse mentoring team with complimentary skills has been put in place to
aid the investigator in their career goals.

Public health relevance
Project Narrative (3 sentences max): Kidney stones represent a significant burden on the US healthcare system with approximately 10% of Americans suffering from this disease at some point in their life. The objective of this proposed body of work is to develop a nanotechnology based treatment that can specifically target kidney stones and cause stone comminution through irradiation with a low power near-infrared laser in a non-contact mode. This project will advance the career development of the investigator and provide the basis for the introduction of a paradigm changing treatment modality for urolithiasis.